Impact of Historically Black Colleges and Universities on Late-life Cognition in Black Adults

PROJECT SUMMARY/ABSTRACT
Black-White inequities in Alzheimer’s Disease and Related Dementia (ADRD) are a pressing public health
problem: prevalence is almost double for Black adults aged 65-84. ADRD is a leading cause of death in the
United States, affecting an estimated 5 million Americans. ADRD is a progressive disease impacting the parts
of the brain that control thought, memory, and language. Unlike heart disease and cancer, death rates from
ADRD are rising. ADRD prevalence is projected to decrease for White and increase for Black adults over time.
Higher education is a strong social determinant of lower ADRD risk. However, large Black-White inequities in
ADRD persist at the highest levels of education. Unfortunately, most nationally representative studies on ADRD
are comprised of White adults. To address this disparity, we must consider risk factors that impact Black
Americans uniquely as opposed to White experiences. Though structural racism is implicated as a fundamental
cause of higher education gaps, little is known about if, and to what extent, uniquely Black college experiences
influence ADRD risk in Black adults, specifically Historically Black Colleges and Universities (HBCUs). HBCUs
are comprised of predominantly Black students (76%) and uplift Black individuals as well as Black communities
through economic and cultural empowerment, increased social and political capital, and neighborhood
revitalization and pride. Thus, early life exposure to HBCUs is a promising and unexplored mechanism that may
improve later-life ADRD outcomes and inequities for Black adults.
This K99/R00 study proposal leverages three large, well-established racially diverse national panel datasets to
investigate the impact of early life exposure to HBCUs on vascular risk factors of ADRD, late-life incidence of
ADRD, and all-cause mortality in Black adults; The Health and Retirement Study (HRS), Reasons for Geographic
and Racial Differences in Stroke study (REGARDS), and Project Talent. We will apply quasi-experimental
methods to evaluate the causal effects of (1) HBCU attendance and completion compared to a Predominantly
White Institution (PWI), (2) early life HBCU proximity compared to a PWI through educational attainment, and
(3) state and federal funding policy of HBCUs compared to PWIs during college-aged years.
The research plan is complemented by an exceptional multidisciplinary mentorship team at the University of
California San Francisco and training activities that build on the candidate’s background in racism-related
research by providing new training in (1) life course determinants of ADRD, (2) data harmonization, and (3)
causal effects of social and policy measures. The combined research and training plans will prepare the applicant
for a successful independent epidemiology research career specializing in the study of structural racism as a
social determinant of ADRD and inequities. This study aligns with NIA’s strategy for reducing health disparities
and harmonizing population data. Findings from this proposal will provide critical insight into our understanding
of uniquely Black college experiences as a source of cognitive resilience for Black adults.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Project Narrative Though higher education is a strong social determinant of lower risk of Alzheimer’s Disease and Related Dementias (ADRD), large Black-White inequities in ADRD persist among college educated adults. Given that the majority of ADRD studies are comprised of White adults, we must consider educational risk factors that uniquely impact Black Americans to address this disparity, specifically Historically Black Colleges and Universities (HBCUs). This proposed research will advance our understanding of early life exposure to HBCUs as a source of cognitive resilience for Black adults and potential target for future interventions. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page